Role of ADP-ribosylation in Stress Granules

Project Summary
Membrane-less structures are prevalent in cells and executing unique functions (e.g., DNA
repair foci and nucleoli for making ribosomal subunits). The mechanisms by which their
formation, size, number, and dynamics are regulated, however, remain unclear. Emergent
studies revealed that their formation can be partly explained by a biophysical phenomenon
known as liquid-liquid phase separation, whereby the nucleoplasm and cytoplasm are
considered complex fluids that stably segregate like oil and water. Phase separation is often
triggered when proteins bind to a common scaffold such as the nucleic acids DNA and RNA,
resulting in the condensation of proteins to form higher-order structures. We previously
discovered that an under-studied nucleic acid called poly(ADP-ribose) (PAR) is critical for the
formation of a class of membrane-less organelles implicated in cancer, virus infection and
neurodegeneration called stress granules. Stress granules are cytoplasmic RNA-protein
assemblies formed in different sizes in response to stressors such as hypoxia, oxidative stress
and heat shock. Most granule components dynamically exchange with the surrounding
cytoplasm, and individual granules grow in size over time through fusion. Notably, stress
granules in models of neuropathological diseases, such as amyotrophic lateral sclerosis (ALS),
have slower exchange dynamics and are less able to fuse. However, the molecular factors that
control the stress granule dynamics and fusion (which affects size and number of granules)
remain poorly understood. In this proposal, we will (1) determine how PAR regulates phase
separation in stress granules using innovative techniques to define critical parameters of ADP-
ribosylation for stress granule formation in cells and in vitro, and (2) determine whether PAR-
protein interactions regulate stress granule fusion using mutagenesis, live-cell imaging,
biophysical methods and proteomics. Projected Impact: Besides its role in stress granules, PAR
is also critical for the formation of time- and location-specific membrane-less structures,
including DNA repair complexes and nucleoli. This proposal will thus advance the field by
defining critical parameters for physiologically relevant PAR-mediated phase separation and by
identifying ADP-ribosylated proteins required for these phenomena. Given that PARPs are
druggable and actively targeted by pharmaceutical companies, next-generation inhibitors may
be designed to modulate the formation and dynamics of physiological and pathological
membrane-less structures in neurological or other diseases.

Public health relevance
Project Narratives This proposal focuses on the regulation of a class of membrane-less structures implicated in cancer, virus infection and neurodegeneration called stress granules by an understudied, but therapeutically important, poly(ADP-ribose). Given that the enzyme family that controls poly(ADP-ribose) formation is druggable and actively targeted by pharmaceutical companies, next-generation inhibitors may be designed to modulate the formation and dynamics of physiological and pathological membrane-less structures in a range of diseases.